Crosstalk Between Nurr1 and Risk Factors of Parkinson's Disease and its Regulation by Nurr1's Ligands

Abstract:
Selective degeneration of midbrain dopaminergic (mDA) neurons in the substantia nigra and abnormal
accumulation and aggregation of -synuclein in Lewy bodies are hallmark pathological features of Parkinson’s
disease (PD). Currently, available treatments are symptomatic and there is no treatment that can halt or slow
down the disease progression. Based on extensive studies on transcriptional regulation of mDA neurons from
this and other laboratories, the orphan nuclear receptor Nurr1 (also known as NR4A2) has emerged as a master
regulator of mDA neurons and a promising target for therapeutic development in PD. Although Nurr1 has been
considered a ligand-independent, constitutively active transcription factor, we identified both synthetic
(amodiaquine, chloroquine, and glafenine) and endogenous ligands (prostaglandin E1 (PGE1) and PGA1), which
directly interact with the ligand binding domain (LBD) of Nurr1 and activate its transcription function with distinct
mechanisms. Furthermore, our preliminary data showed that Nurr1 expression is significantly compromised by
both prolonged exposure to neurotoxin and overexpression of -synuclein. Based on these results, we
hypothesize that Nurr1 is an “adopted” nuclear receptor whose transcriptional function is significantly modulated
by both synthetic and native ligands and that there is functional crosstalk between Nurr1 and PD risk factors. To
address these hypotheses, we propose to investigate the following questions. First, we will address whether
there exist additional endogenous ligands in the brain and will investigate the underlying molecular mechanisms
how these novel ligands regulate Nurr1’s transcriptional function by identifying its coregulators and delineating
their structure-activity relationships. Second, we will investigate whether there is crosstalk between Nurr1 and
PD risk factors such as -synuclein and how Nurr1’s ligands regulate this crosstalk. Third, using in vivo models
of PD, we will systematically investigate whether Nurr1’s optimal synthetic and/or endogenous ligands can
provide mechanism-based neuroprotection for eventual application as novel therapeutics for PD. If successful,
these studies will advance our understanding of Nurr1’s function and regulation by its ligands in health and
disease, and address whether Nurr1 can be a “druggable” target for PD.

Public health relevance
Project Narrative: Parkinson’s disease (PD) is a common neurodegenerative disorder affecting more than a million patients in the USA alone, and currently there are no treatments that can halt or slow down the disease progression. The nuclear receptor Nurr1 is essential not only for development and maintenance but also for protection of midbrain dopamine neurons from inflammatory insults, rendering it a promising drug target for PD. Based on our recent data identifying synthetic and native ligands that can interact with the ligand binding domain of Nurr1, leading to its activation, we will systematically investigate how these ligands regulate Nurr1’s crosstalk with genetic and environmental risk factors of PD (e.g., -synuclein and neurotoxin) and whether they can translate into future therapeutic development for neuroprotective and disease-modifying treatment of PD.